Diet transformation by the microbiome and its impact on bacterial infection

Project Summary
Food contains a vast collection of bioactive small molecules that encounter enormous populations of
commensal microbes in the gastrointestinal tract. Microbiome metabolism has been reported across dietary
compound classes; however, the microbial enzymes that metabolize dietary small molecules can be highly
substrate specific and these activities can vary widely between individuals. The impact of diet on the
microbiome is also well established. Thus, the gut microbiome is likely a determining factor in an individual's
dietary metabolite exposure, with implications for infection, cancer, inflammatory diseases, cardiovascular
diseases, and other diseases impacted by diet. Microbes and diet directly intersect in the context of infections
caused by the food-borne enteropathogens Salmonella enterica serovar Typhimurium and Campylobacter
jejuni, which cause tens of millions of cases of food-borne illness every year, largely through consumption of
chicken and other poultry products. Progress understanding these interactions would transform our ability to
manage this major public health challenge, enabling interventions in humans and in our food chain where diet
can be directly prescribed. This proposal will test the hypothesis that modification of dietary compounds by the
gut microbiota, and disruption of the microbiota by dietary compounds, determines the function of these
molecules in modulating colonization resistance (pathogen exclusion by the microbiome), pathogen growth,
and virulence in humans and in our food chain. In Aim 1, we will generate a systematic map of the metabolism
of over 100 dietary compounds by over 100 gut microbes and microbiomes from two human cohorts and
chickens at the level of communities, species, enzymes, and metabolites. In Aim 2, we will determine how
these compounds modulate colonization resistance in gnotobiotic mouse and gnotobiotic chicken models of S.
Typhimurium and C. jejuni infections. In Aim 3, we will measure how dietary compounds and their microbial
metabolites impact pathogen growth and virulence in vitro, in 2D monolayers derived from intestinal organoids,
and in gnotobiotic animals. Together, these studies will define how the reciprocal interactions between diet and
the microbiome determine the outcome of food-borne infections, a major public health risk.

Public health relevance
Project Narrative Humans carry enormous communities of non-harmful gut bacteria (the microbiome) which have a two-sided relationship with the foods we eat: on one hand, dietary components can disrupt these bacterial communities; at the same time, gut bacteria can change these dietary components. These activities intersect when we encounter food-borne infections, which impact tens of millions of people every year in the USA and are strongly influenced by both diet and the microbiome. This proposal presents a plan to understand how an individual's microbiome transforms (and is transformed by) dietary components in our food, and how these interactions determine the outcome of food-borne infections.